Circuit Mechanisms of Cross-Organ Taste Integration for Feeding in Drosophila

PROJECT SUMMARY
We integrate sensory signals, like smell and taste, to make decisions about the type and quantity of food to eat
on a daily basis. Distinct sensory inputs converge in brain regions that regulate food intake, such as the gustatory
cortex, but the neural circuit mechanisms that integrate sensory information to control food consumption remain
largely unknown. The fruit fly Drosophila melanogaster provides an excellent model system to address this
question, as we can genetically target individual neurons in the fly brain and use the whole-brain connectome to
identify pathways linking sensory input to motor output. Just as humans use multiple sensory cues to evaluate
the quality of food, flies use distinct taste inputs from their legs and feeding organ, the proboscis, to decide
whether to initiate feeding. This study will determine where and how neural circuits in the fly brain integrate
concurrent taste input from the legs and proboscis to regulate feeding, providing a model to more broadly
understand the logic of how neural circuits integrate different food-related signals.
The experiments in Aim 1 will determine how sugar inputs on the legs and proboscis are integrated to regulate
the likelihood that flies will initiate feeding and the quantity of food they consume. In vivo calcium imaging
experiments in Aim 2 will determine how concurrent sugar input on the legs and proboscis influences the activity
of individual neurons in a neural circuit known to respond to sugar and promote feeding initiation. These
recordings of neural activity, combined with an analysis of neuronal connectivity in the whole-brain connectome,
will provide a neural substrate for the behavior identified in Aim 1. Together, the findings from this study will
identify the neural circuit mechanisms that integrate distinct taste inputs to promote adaptive feeding behavior.
The basic principles of chemosensory processing and its role in feeding regulation are conserved across
species. Thus, future work can use our findings to develop hypotheses about the neural circuits that combine
sensory cues to regulate food consumption— and investigate whether these circuits contribute to dysregulated
eating— in rodents and humans.

Public health relevance
PROJECT NARRATIVE Sensory cues like smell and taste interact with each other to shape our daily food choices, but how neural circuits integrate distinct sensory inputs to regulate food intake is largely unknown. By leveraging unique experimental tools to study the connectivity and activity of individual neurons in the fruit fly Drosophila melanogaster, this project will identify neural circuit mechanisms that integrate distinct taste inputs to control food consumption. Future work can extend these findings to other systems to advance our understanding of how the integration of food-related signals may contribute to both healthy and dysregulated eating behavior.